Study Of Health Behavior In School Children

The Health Behaviour in School-aged Children (HBSC) study is a cross-national research survey conducted in collaboration with the World Health Organization (WHO) Regional Office for Europe. The HBSC aims to gain new insight into, and increase our understanding of young peoples health and well-being, health behaviors and their social context. Initiated in 1982 in three countries, there are now over 35 participating countries and regions. The first cross-national survey was conducted in 1983/84, the second in 1985/86, and subsequently every four years using a common research protocol. The U.S. has been associated with the HBSC since 1993/94 and a fully participating member since 1997/98. The most recent survey was just completed for 2005/06. Besides contributing to the international survey, the U.S. simultaneously mounts a nationally representative school-based survey of 10,000 students in grades 6 to 10 using identical data collection methods. Recent major studies from the 2001/02 survey have focused on the prevalence, patterns, determinants, and effects of violence and bullying behaviors, the epidemiology of substance use among young adolescents and the effect of public policy, and physical activity and the relationship to positive and negative health behaviors. With respect to bullying, involvement as bully, victim, or both bully and victim was assessed from nationally representative samples of 113,200 students at averages ages of 11, 13, and 15 from 25 countries, including the U.S. Involvement in bullying varied dramatically across countries, ranging from 9-54%, and was associated with poorer psychosocial adjustment. In all or nearly all countries, bullies, victims, and bully-victims reported greater health problems and poorer emotional and social adjustment. Victims and bully-victims consistently reported poorer relationships with classmates, while bullies and bully-victims reported greater alcohol use and weapon-carrying. Self-report of weapon-carrying, weapon-carrying in school, physical fighting, and being injured in a physical fight was also examined for the U.S. sample with the finding that involvement in each of the violence-related behaviors ranged from 13-23% of boys and 4-11% of girls. Greater odds of involvement occurred with bullying others than being bullied and with bullying that took place away from school than that occurring in school. The adjusted odds for weapon carrying associated with being bullied in school weekly was 1.5; for bullying others in school 2.6; for being bullied away from school 4.1; and for bullying others away from school 5.9. Thus, bullying in the U.S. is generally a marker for more serious violent behaviors, including weapon-carrying, frequent fighting, and fighting-related injury. Studies using the 2001/02 data have looked at the timing of pubertal maturation in association with the increased body size of U.S. adolescents. In girls particularly, early maturation is associated with a higher BMI and overweight. Since other maturational patterns, especially risk-taking behavior, may also be associated with pubertal development, this relationship was investigated in the U.S. HBSC. Examples of risk behaviors examined included whether the adolescent had ever smoked tobacco or drunk alcohol to excess (got drunk). Boys pubertal status was indicated by the appearance of hair on the upper lip (around Tanner pubic hair stage 4) and girls by menarche (between Tanner pubic hair stages 3 and 4). At every age during peak pubertal periods, more mature adolescents were significantly taller and heavier, and the reported frequency of risk behaviors increased with age and maturational status. Adjusting for age, ethnic differences, residence and perception of family affluence, more mature boys with facial hair and post-menarcheal girls were almost twice as likely to have ever smoked or reported getting drunk. Thus, not only is the timing of pubertal maturation a factor in the development of adolescent overweight, but also in the development of risk behaviors. Current analyses are examining patterns of health risk behaviors across racial and ethnic groups, the effect of laws governing youth access to tobacco and exposure to tobacco smoke on tobacco use by youth, and the relationship of physical activity and sedentary behaviors with positive and negative health indicators.